Exploiting myeloma proteome remodeling to extend proteasome inhibitor efficacy

PROJECT SUMMARY/ABSTRACT
Multiple myeloma is an aggressive hematologic malignancy that remains incurable despite recent progress.
This disease of malignant plasma cells is fundamentally associated with aberrant protein homeostasis, defined
by an extremely high burden of immunoglobulin synthesis. Proteasome inhibitors (PIs), a widely-used first-line
therapy in myeloma, are thought to directly take advantage of this aberrancy by increasing unfolded protein
stress leading to cell death. However, this mechanism is not fully proven, and further insight into PI-induced
cell death may lead to more effective combination strategies. In addition, PI resistance is a major clinical
problem in myeloma, and new strategies are needed to overcome this condition. Here, we hypothesize that
the remodeling of the plasma cell proteome after therapy is central to both PI response and resistance. We
specifically propose that proteome remodeling is mediated through rewiring of proteostasis pathways involving
chaperones, the VCP/p97 complex, and the ubiquitin-proteasome system, as well as through changes to the
alternative splicing landscape, as mediated by post-translational modification of the splicing machinery. To
explore this hypothesis we will take advantage of novel pharmacologic and genetic perturbation tools, cellular
and biochemical assays, in vivo models, clinical trial genomic data, primary sample analysis, RNA sequencing,
and mass spectrometry approaches. The overall goals of this proposal are 1) develop new therapy strategies
either in combination with PIs or in the PI-refractory setting, and 2) describe a new, systematic approach to
probe the architecture of proteostasis networks. Importantly, our preliminary results challenge existing
paradigms related to PI efficacy. In Aim 1, we address paradoxical findings relating the unfolded protein
response, the interaction between the p97 degradation machinery and PIs, and the relevance of inducible
HSP-family chaperones. We will take advantage of novel pharmacology available to us, including active site
and allosteric inhibitors of p97 and allosteric inhibitors of HSP70, in combination with functional genetics by
CRISPR interference, to define the role of central protein homeostasis nodes defining PI response and
resistance. Furthermore, we will use our unique expertise in pulsed-SILAC proteomics to determine specific
substrates of the p97 machinery and the proteasome in the presence of clinically-relevant resistance
modifications. Toward Aim 2, our preliminary studies using unbiased mass spectrometry have revealed
significant phosphorylation of the spliceosome after PI treatment. We first aim to characterize the relationship
between specific alternative splicing events and proteome remodeling after PIs. We then aim to extend our
promising preliminary data demonstrating the efficacy of splicing inhibitors as a new anti-myeloma therapy.
Overall, the studies here will have a direct impact on delineating the surprisingly broad range of PI-mediated
effects in plasma cells, validate the novel therapeutic strategy of splicing inhibition, and reveal new mechanistic
approaches to dissect proteostasis networks and alternative splicing that could extend far beyond myeloma.

Public health relevance
PROJECT NARRATIVE Multiple myeloma is an aggressive blood cancer that remains without a cure despite recent progress. Here, we aim to uncover new treatment strategies that target how tumor cells respond to the first-line therapy of proteasome inhibition, which either cause them to grow or become resistant to therapy. These investigations will lead to further understanding of new ways to improve clinical outcomes for myeloma patients.